Short-Term Institutional Research Training Grant

Abstract
Research is an essential element any medical professional’s training and professional development.
However, many medical students have limited opportunities to participate in laboratory, clinical or translational
research during their training. As a consequence, the number of physicians that can be recruited into research
careers is modest. The Medical Student Summer Research Program (MSSRP) allows medical students from
any US medical school to experience research firsthand by spending 9-10 weeks conducting research and
analyzing data in the clinical, outcomes, and basic science research laboratories of established faculty
investigators at the University of Cincinnati College of Medicine (UCCOM) and the Cincinnati Children’s
Hospital Medical Center (CCHMC). The goal of the MSSRP and this Short-Term Medical Student Training
Grant (T35 DK060444) is to provide medical students with short-term opportunities to participate in research
projects that align with the NIDDK mission.
To achieve this goal, we provide high quality, structured interactions with UCCOM / CCHMC faculty
through focused research projects and outstanding mentorship. Since NIDDK support of the MSSRP began in
2001, T35 DK 060444 has supported 299 medical students and been cited in 163 publications. The number of
UCCOM faculty with NIDDK-focused research programs has expanded considerably in recent years with a
significant increase in NIDDK funding from $16.6 million in 2013 to $36.0 million in 2023. A partial list of
research areas includes 1) gut microbiome and mucosal immunology, 2) inflammatory diseases of the liver and
viral hepatitis, 3) liver development and hepatocellular carcinoma, 4) allergic and immune responses, 5)
urologic and hematologic disorders, 6) organoid biology, 7) enterocyte biology, mucosal inflammation, and
inflammatory bowel disease, 8) non-alcoholic fatty liver disease, 9) intestinal transport/absorption, 10) obesity
and diabetes, 11) renal injury and rejection, renal carcinoma, chronic kidney disease, and 12) nutritional
aspects of health and disease.
The UCCOM has an outstanding track record in the development and recruitment of under-represented
minority (URM) medical students, both locally and nationally. Since 2019, newly admitted classes have
consisted of 51% women and 19% URM. Through its Office of Diversity, Equity, and Inclusion, UCCOM has
several recruitment and retention efforts specific to under-represented students and those from disadvantaged
backgrounds. Faculty demographics for the UCCOM (excluding Pediatrics) includes 1483 faculty of whom
41% are women, 69% white, 4% African American, 22% Asian, and 3% Hispanic. In June 2023, UCCOM
counted 141 individuals across 26 distinct departments and divisions. These data attest to the large number of
URM students and faculty that can participate in the MSSRP and support our goal of having 20% of our 12
requested positions filled by URM/diverse students.

Public health relevance
Project narrative Many medical students have limited opportunities to participate in laboratory, clinical or translational research during their training. Consequently, the rate at which physicians can be recruited into research careers is low. The goal of the Medical Student Summer Research Program (MSSRP) and this Short-Term Medical Student Training Grant (T35 DK060444) is to provide medical students with short-term opportunities to participate in research projects that align with the NIDDK mission.